Characterizing Natural Product Mediated Microbial Interactions

Project Summary
The human body hosts a diverse microbial community, interacting through the production, detection, and utilization of a
structurally diverse set of specialized metabolites. These metabolites influence community structure by mediating
commensal, competitive, and cooperative intra- and inter-species interactions. However, it the system is perturbed, the
community can shift from a benign commensal community to a pathogenic one. My group’s long-term goal is to define
metabolite-mediated relationships between members of the human microbiota and elucidate their role in community
dynamics. We hypothesize that the metabolite-driven interactions of pathogenic communities influence susceptibility of
pathogens to antimicrobial treatment. The overall objective of this proposal is integrate cheminformatics analysis of
untargeted metabolomics data with physiologically relevant in vitro model systems to elucidate novel chemistry mediating
community recalcitrance to antimicrobial therapies. The proposed research is significant because it will provide a
fundamental understanding of how specialized metabolites impact the structure and function of the microbiome.

Public health relevance
Project Narrative The human body is populated by a diverse community of bacteria and fungi. These microbes harbor the ability to produce a variety of small molecules that influence the composition of our microbial communities. Our research aims to elucidate the chemical mechanisms that microbes use to communicate with one another and to use these insights to develop new therapeutic strategies for treating disease.